Administrative Core

PROJECT SUMMARY
The Administrative Core will provide coordination and oversight across all Center activities. It will help maximize
interactions and synergies and will enable optimal use of available research infrastructure, including Core
resources and services, and a state-of-the-art high-performance computing environment. It will also facilitate
participation of CaST members to CSBC activities, ensure that programmatic feedback from the CSBC is
integrated into the Center’s operations, and administer the one-year intra-Center pilot research projects. An
effective management structure will be put in place to ensure that the Center’s complex objectives are achieved
in timely fashion, including an Executive Steering Committee (ESC) —comprising the Center’s Directors, Center
Administrator, Project/Core Leads, and NCI program officers—which will oversee the Center’s operations and
provide overall guidance to the investigators; a Center Administrator who will meet frequently with Project and
Core leads to track progress on project activities, facilitate interactions and integration between Projects, and
ensure that the decisions made at the ESC meetings are properly communicated; and a Data Manager who will
ensure that resources and data generated by the Center are consistently annotated and prepared for submission
to NIH repositories in a timely and effective manner. The ESC will meet quarterly to candidly assess Project
progress, address operational and research issues that require corrective action, prioritize use of Center
resources, make decision about Pilot Project awards, and ensure coordination with related NCI and NIH
activities. The Administrative Core will provide logistical support for the annual NCI site visit, coordinate
preparation of progress reports, monitor compliance with regulatory requirements, and provide timely fiscal
reviews and budget analysis. In support of these efforts, the Core will define and track a broad collection of
quantitative metrics to assess the quality and utility of Center deliverables. The Core will be responsible for
assembling a world class scientific External Advisory Committee (EAB) to advise the Center’s co-Directors and
to provide an impartial assessment of the Center’s research program. In addition to ad hoc communications, the
EAB members will meet in person once a year at the Center’s NCI site visit, where they will attend scientific
presentations from Project and Core investigators and will offer feedback on research progress and future
directions, as well as advice on program management and the administration of the Pilot Project program. The
Administrative Core will coordinate the participation of Center personnel to all Consortium activities, including
attending meetings and workshops, contributing to working groups and technical committees, and interfacing
with other NIH initiatives. Finally, it will support a broad educational program implemented through the Outreach
core, aiming to expand inclusivity and diversity in Cancer Systems Biology by offering education and learning
opportunities to underprivileged high school and college students from minority-serving institutions in New York
City and other big cities.